MFRPS-to achieve & maintain full conformance, RRT-Improve food safety in Missouri, FPTF-To organize Food Protection Task Force meetings.

Manufactured Food Program Standards:
1. Maintain conformance with the Manufactured Food Regulatory Program Standards.
2. Leverage national standards as the continuous improvement system for the DHSS
manufactured food program.
3. Provide manpower necessary to prioritize and inspect firms at frequencies that are
based on food safety risks.
4. Engage as a contributor to national initiatives to support continuous improvement of the
MFRPS.
Rapid Response Teams:
1. Maintain the Missouri Rapid Response Team (MRRT) multidisciplinary, multiagency
multi-hazard response capabilities to respond to food and feed contamination and illness
outbreaks, while also seeking continuous improvement and opportunities for innovation.
2. Continue outreach to Missouri's 115 autonomous Local Public Health Agencies (LPHAs)
with more training and exercises.
3. Providing a Subject Matter Expert (SME) Center to assist other states with additional
expertise and surge capacity in emergencies, while also working to expand the number of
SME Centers.
4. Contributing to national initiatives and workgroups, including those that continue
development of multi-state approaches to after action reviews, reports and
improvement plans.
Food Protection Task Force:
1. To organize and host annual FPTF meetings to foster communication, cooperation and
collaboration with regulatory agencies, industry food safety professionals, academia and
consumers.
2. Provide an update to the current website to include a secure portal to facilitate sharing
and communication between stakeholders of the FPTF.
3. To provide a forum to meet training needs in emerging food safety arenas like:
foodborne illness investigations, food defense, active managerial control, integrated food
safety, consumer trust, and allergens.

Public health relevance
Through conforming to national standards, Missouri's manufactured food regulatory program (MFRPS) will apply the best practices necessary to integrate with other state and federal programs to minimize foodborne illness risks to the public, improving food safety in Missouri and nationally. The Missouri Department of Health and Senior Services propose to maintain its interagency Rapid Response Team (RRT) for managing large scale outbreaks involving food and feed. The Missouri Food Protection Task Force (FPTF) will serve as medium for food safety professionals, which will include training opportunities as well as forums for discussion on food safety topics.